A Human Organoid Model of Polycystic Kidney Disease

A HUMAN ORGANOID MODEL OF POLYCYSTIC KIDNEY DISEASE
!
PROJECT SUMMARY
Polycystic kidney disease (PKD) is the world's most common life-threatening genetic disease and
fourth-leading cause of kidney failure, affecting approximately 12 million people worldwide. In PKD,
the normal tubular architecture of the kidneys and other organs is gradually replaced by cysts and
fibrosis. There is no cure for PKD, and candidate therapeutics are of uncertain efficacy and safety.
PKD is commonly inherited as a germline heterozygous loss-of-function mutation in PKD1 or PKD2,
encoding polycystin-1 (PC1) and polycystin-2 (PC2), respectively. These large, transmembrane
proteins form a channel-receptor complex at the primary cilium and other sites. It is not yet known
how mutations result in cyst formation from tubular epithelial cells. A major barrier to deciphering PKD
mechanistically is the lack of experimentally accessible models that faithfully recapitulate PKD-
specific cystogenesis from tubules. Primary and immortalized cell lines are heterogenous, de-
differentiated, non-human, or represent only later stages of disease, while animal models differ
substantially from humans and are challenging to decipher mechanistically. To overcome this gap,
our laboratory is pioneering the use of human pluripotent stem cells (hPSC) for modeling PKD.
hPSC represent a very early embryonic state and provide a renewable source of patient-matched
human cells for analysis and regeneration. We have established techniques to differentiate hPSC into
human kidney organoids, which are complex, multicellular structures with patterned segments that
resemble nephrons. We have further compared gene-edited and patient-derived organoids to mouse
and human tissue samples with disease to complement and validate this new system. In hPSC with
PKD mutations, we have identified several disease-relevant phenotypes, including cystogenesis from
kidney organoid tubules. The goal of this proposal is to elucidate the mechanistic determinants of
human PKD cystogenesis in kidney organoids. Based on our preliminary data, we hypothesize that
balanced expression of PC1 and PC2 regulates physical adhesion between the kidney tubule and its
microenvironment. In Aim 1, we will establish a more faithful experimental model of human PKD by
quantifying cystogenesis in heterozygous kidney organoids. In Aim 2, we will investigate how
polycystin protein levels are controlled by clarifying the mechanisms underlying PC1 loss in PKD2-/-
cells. Finally, Aim 3 will explore a novel hypothesized molecular pathway for PKD by identifying
defects in cell adhesion during cyst initiation. Key findings will be validated in primary PKD tissues
and non-organoid cells. Collectively, these studies will unveil critical molecular pathways that underlie
the enigmatic process of cyst formation, revealing new potential targets for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Polycystic kidney disease (PKD) is the most common genetic form of kidney disease, affecting twelve million people, in which tiny tubes in the kidneys and other organs form balloon-like cysts. We have recently discovered a way to grow human `mini-kidneys', which can form cysts similar to those seen in human PKD patients in a genetically inheritable way. The goal of the proposed research is to use these mini-kidneys to understand how cysts arise in PKD and guide strategies for therapeutic intervention.